Investigating the Role of PFKFB4 in the Immune Regulation of Lung Cancer

PROJECT SUMMARY
Lung cancer is responsible for the highest number of cancer-related deaths in the world. Non-small cell lung
cancers (NSCLC) form the majority of lung tumors. These tumors are often discovered at an advanced stage
when options are limited and survival is poor. Effective strategies are desperately needed to improve outcomes
from this devastating cancer.
NSCLCs universally exhibit a high rate of glycolysis to support their rapid growth and spread. A key rate-limiting
step in the glycolytic pathway is catalyzed by the enzyme 6-phosphofructo-1-kinase (PFK1). PFK1 is activated
by fructose-2,6-bisphosphate (F26BP) - produced by the 6-phosphofructo-2-kinase/fructose-2,6-bisphosphatase
family of enzymes (PFKFB1-4). In previous studies, we found that the PFKFB4 enzyme is highly expressed in
NSCLCs and established its requirement in the regulation of glucose metabolism and growth in these tumors.
We have developed a potent novel small molecule inhibitor of PFKFB4, MPN-22, that selectively inhibits
PFKFB4, and decreases NSCLC glycolysis and proliferation and tumor growth in vivo. In recent studies, we have
found that immunosuppressive Th17 and γδT17 cells express F26BP and PFKFB4 and that MPN-22
administration in lung tumor-bearing mice decreases the frequency and activity of these cells. We hypothesize
that PFKFB4 is required for Th17/γδT17 activity and that MPN-22 will decrease their activity resulting in an
increase in activated CD4+ and CD8+ T cells. We further postulate that MPN-22 will potentiate the antitumor
activity of immune checkpoint inhibitors (ICIs) to effectively decrease NSCLC growth. We propose to examine
the effects of PFKFB4 inhibition with MPN-22 on Th17/γδT17 cell development and activity in vitro and
additionally determine the effects of MPN-22 on immune cells and tumor progression and its efficacy in
combination with ICIs in relevant oncogene-driven models of lung cancer. We anticipate that MPN-22 will
significantly decrease the activity of immunosuppressive T cell subsets and increase the efficacy of ICIs in
NSCLC. The ultimate goal of our studies is to develop an effective therapeutic strategy to successfully
treat and improve outcomes in advanced NSCLC.

Public health relevance
NARRATIVE Lung cancer is the most frequent cause of cancer-related death and non-small cell lung cancer (NSCLC) is the most commonly diagnosed lung cancer. Despite therapeutic advancements, outcomes from NSCLC remain poor. We anticipate that our studies will demonstrate the importance of the PFKFB4 enzyme in the activity of immunosuppressive T cells and the efficacy of PFKFB4 inhibition in augmenting effects of immune checkpoint inhibitors and decreasing tumor progression in NSCLC. Accordingly, the proposed studies seek to provide rationale to support the targeting of PFKFB4 (in combination with immune checkpoint inhibitors) as a novel therapeutic strategy to reduce the high mortality associated with NSCLC.